COMPUTER AIDED ANALYSIS OF ELECTROCARDIOGRAPHY

These studies are directed toward evaluation of the prognostic power of the electrocardiogram when analyzed by advanced computer methodology and the predictive accuracy of diagnostic criteria when implemented in ECG computer programs. The use of well documented populations and multivariate statistical techniques in designing new criteria are also subjects under investigation. Studies have been pursued in collaboration with NHLBI and Framingham personnel and with the European consortium (CSE).